Anesthesiology Research Training

Project Summary
The proposed program will provide support for postgraduate research training within the Department of
Anesthesiology within the Health Science Division of Columbia University. Qualified applicants will have
committed to or be enrolled in postgraduate training in anesthesiology. The candidate pool is largely derived
from an established research residency track (Apgar Scholars Society). The program will provide for four
trainees, typically two in their fifth and two in their sixth postgraduate years. Research opportunities are offered
by twenty two participating faculty members with proven records of success in the training of postdoctoral
fellows, both within the Department of Anesthesiology as well as from seven collaborating
departments/divisions, two in basic sciences: Basic Psychiatry (Division of Molecular Therapeutics),
Physiology and Cellular Biophysics, and five partnering clinical departments/divisions: Pulmonary
Medicine, Cardiology, Neurology, Neurosurgery, and Psychiatry. Research areas include, but are not
limited to, modulation of neurotransmission by excitatory amino acids; molecular mechanisms of neuronal
plasticity in chronic pain; structure/function of ligand gated ion channels; smooth muscle cell signaling;
adenosine receptor physiology; mechanisms of organ injury and protection from ischemia-reperfusion injury;
molecular mechanisms of airway remodeling in chronic lung disease; clinical and basic studies in
anesthetic-mediated developmental neurotoxicity, biomarkers of clinical organ injury, and epidemiology
studies of clinical outcomes. With the continued support of the Department of Anesthesiology following
training, this program will continue to lead to the establishment of independent physician-scientists modern
methods and techniques to help meet the research needs of the specialty of anesthesiology in the twenty first
century.

Public health relevance
Narrative The proposed program will provide support for postgraduate research training in the Department of Anesthesiology within the Health Sciences Division of Columbia University to qualified applicants who have committed to or are enrolled in postgraduate training in anesthesiology. The goal of this training is to provide for the next generation of physician-scientists and researchers who will seek to improve medical care in areas relevant to perioperative care, palliative care, acute and chronic pain, and health services delivery.